Prevention of heart failure with IL-1 blockade: a mechanistic study

Project Summary
This application is for a Mechanistic Clinical Study (R01) entitled “Prevention of HF with IL-1 blockade: a
mechanistic study” submitted by Antonio Abbate MD, PhD and Benjamin Van Tassell, PharmD. Despite
improvements in early diagnosis and treatment, ST-segment elevation myocardial infarction (STEMI) remains a
leading cause of morbidity and mortality in the US. Patients with STEMI are significantly increased risk for
developing heart failure. While numerous studies have identified inflammation as a risk factor for heart failure,
there are currently no anti-inflammatory therapies with a documented benefit in patients with STEMI. Among the
different inflammatory mediators, Interleukin-1 (IL-1) occupies a central role, not only because it is a key mediator
of systemic inflammation (i.e. fever) but also because IL-1 is sufficient to cause significant depression of cardiac
function, impaired cardiac reserve, and worsened cardiac remodeling in acute myocardial infarction. In a recent
study, treatment with anakinra (recombinant IL-1 receptor antagonist) in patients with STEMI significantly blunted
the acute systemic inflammatory response and fewer patients treated with anakinra developed heart failure
during the following year. This application will confirm and expand these findings by studying the mechanism by
which IL-1 blockade with anakinra may prevent heart failure. We propose the IL-1 blockade with anakinra
preserves cardiorespiratory fitness through cardiac diastolic/systolic reserve, affecting quality of life, and
incidence of heart failure in patients with STEMI. We propose to conduct a randomized, double-blind, placebo-
controlled, phase II clinical trial (n=84) with 1:1 allocation to anakinra or placebo for 14 days among patients with
acute STEMI and state-of-the-art cardiopulmonary exercise testing, cardiac imaging with Doppler
echocardiography and cardiac magnetic resonance, biomarkers and quality of life assessments up to 12 months.

Public health relevance
Project Narrative Despite improvements in early diagnosis and treatment, ST-segment elevation myocardial infarction (STEMI) remains a leading cause of morbidity and mortality in the US, and patients with STEMI are at significantly increased risk for developing heart failure. Numerous studies have identified inflammation as a risk factor for heart failure, and in phase II clinical trials, Interleukin-1 (IL-1) blockade has shown to blunt the acute inflammatory response and prevent heart failure in patients with STEMI. This application will evaluate the mechanism by which targeted IL-1 blockade may preserve cardiorespiratory fitness and cardiac reserve, and prevent the incidence of new-onset heart failure in patients with STEMI.